Biomarkers of Psychological Risk and Resilience in World Trade Center Responders

DESCRIPTION (provided by applicant): The worker response to the World Trade Center (WTC) attacks was unprecedented in scope, involving tens of thousands of traditional and non-traditional responders in rescue, recovery, and clean-up efforts. Posttraumatic stress disorder (PTSD) arising in response to equally unprecedented traumatic exposures, and characterized by disabling intrusive memories of the disaster, repeated nightmares, avoidance of disaster reminders, increased fear of another attack, disrupted sleep and other symptoms, is both highly prevalent (about 14%) and persistent in WTC responders, even over a decade after 9/11. The proposed study aims to fill a major gap in our understanding of the development of this disabling condition by conducting a multi-level assessment of vulnerability to PTSD in a diverse sample of 500 professional (i.e., police) and non-traditional (i.e., construction workers) WTC responders recruited from a large responder cohort followed prospectively at the WTC Medical Monitoring and Treatment Program (WTC- MMTP) at the Mount Sinai School of Medicine. We have previously identified four distinct trajectories of PTSD symptoms over time in this cohort of over 10,000 responders: chronic PTSD, delayed-onset PTSD, recovering and resistant trajectories. In this project we will study 500 WTC responders (125 selected from each of the four trajectories) to identify a range of exposure, psychological and biological factors that distinguis responders in the four trajectories. This assessment will include in-person psychiatric, medical, cognitive and psychosocial evaluations, as well as collection of blood and urine samples for testing. Testing will include (1) measurement of cortisol and its metabolites in urine; (2) measurement of cortisol and adrenocorticotropin hormone (ACTH) levels in blood before and after administration of a steroid, dexamethasone (dexamethasone suppression test); (3) measurement of the inhibition of lysozyme synthesis in blood cells by dexamethasone, and index of glucocorticoid receptor sensitivity in blood cells; (4) the identification of gene variant associated with increased risk for PTSD; (5) measurement of the expression levels of two different genes previously found to be associated with risk for PTSD -the gene coding for the glucocorticoid receptor (GR) and the gene coding for FKBP5, a modulator of GR sensitivity-; and (6) measurement of methylation levels of the GR and FKBP5 genes (a mechanism by which environmental influences such as traumatic experiences can modify genetic effects). The goal of the study is to further the field's understanding of PTSD risk and protective factors in disaster responders with varying degrees of preparedness and training in disaster response. Findings on risk factors can be used to improve future prevention and treatment strategies, while findings on protective factors can be applied to bolster resilience in rescue and recovery workers prior to trauma exposure.

Public health relevance
PUBLIC HEALTH RELEVANCE: Posttraumatic stress disorder (PTSD) arising in response to the World Trade Center (WTC) disaster is one of the most prevalent and persistent psychiatric disorders among workers involved in rescue, recovery, and clean-up efforts in response to this disaster, even several years after 9/11. The proposed study will employ a multi-level approach to study clinical, psychosocial, neuroendocrine, genotypic, gene-environment interaction, and molecular factors associated with PTSD risk and resilience in a sample of 500 WTC responders selected from a cohort of over 10,000 responders exhibiting four distinct longitudinal PTSD symptom trajectories: chronic PTSD, delayed-onset PTSD, recovering, and resistant trajectories. Findings on risk factors can be used to improve future prevention and treatment strategies, while findings on protective factors can be applied to bolster resilience in rescue and recovery workers prior to trauma exposure. __SpecificAimsTextDelimiter__ 2. Specific Aims: The worker response to the World Trade Center (WTC) disaster was unprecedented in scope, involving tens of thousands of traditional and non-traditional responders in rescue, recovery, and clean- up efforts. Posttraumatic stress disorder (PTSD) arising in response to equally unprecedented traumatic exposures, and characterized by disabling re-experiencing, avoidance and hyperarousal symptoms, is both highly prevalent (about 14%) and persistent in WTC responders, even over a decade after 9/111-8. The proposed study aims to fill a major gap in our understanding of the development of this disabling condition by conducting a multi-level assessment of vulnerability to PTSD in a diverse sample of 500 WTC responders recruited from a large responder cohort followed prospectively at the WTC Medical Monitoring and Treatment Program (WTC-MMTP) at the Mount Sinai School of Medicine. This assessment will include comprehensive evaluations of clinical, functional neuroendocrine, genotypic, gene-environment interaction, and molecular factors studied independently, as well as in concert, in WTC responders from 4 longitudinal PTSD symptom trajectories: severe chronic PTSD, delayed-onset PTSD, recovering, and resistant trajectories. Specific Aim 1: To identify differences in hypothalamic-pituitary-adrenal (HPA) axis function associated with 4 distinct longitudinal trajectories of posttraumatic stress disorder (PTSD) symptoms in 500 WTC responders Current PTSD diagnostic status and symptom severity will be determined by comprehensive, in-person clinical assessments. Hypotheses: (a) Responders in the chronic PTSD and delayed-onset trajectories will exhibit decreased 24-hour urinary cortisol excretion and metabolites, increased sensitivity to glucocorticoids in lymphocytes (quantified by examining the differential effects of dexamethasone (DEX) on the inhibition of lysozyme synthesis in lymphocytes), and increased suppression of plasma cortisol and adrenocorticotrophin (ACTH) response to a low (0.25 mg), and therefore discriminating, dose of DEX; (b) Responders in the recovering trajectory will exhibit intermediate evidence of HPA axis dysfunction compared to responders in the resistant and chronic PTSD trajectories. We will further examine associations between HPA axis function and WTC-related exposures, as well as cumulative lifetime trauma exposure. Specific Aim 2: (2a) To examine genotype-by-environment interactions whereby variation in genetic risk for PTSD modifies the relation among WTC-related exposures and PTSD symptom trajectories at Time 1, as well as over time, by testing whether a genetic risk score for PTSD is associated with PTSD symptom trajectories and whether its effect is modified by WTC-related exposure. Hypotheses: Genetic vulnerability will modify the relation between WTC-related exposure and PTSD symptom trajectories over time. Specifically, (a) Responders with high genetic vulnerability and high exposure will have higher symptoms at Time 1; (b) Responders with high genetic vulnerability and high exposure will be more likely to exhibit a chronic PTSD trajectory over time; and (c) Responders in the delayed-onset and recovering PTSD trajectories will exhibit intermediate genetic vulnerability and exposure severity. (2b) Additionally, we will compare GR and FKBP5 gene expression levels between the 4 PTSD symptom trajectories using quantitative polymerase chain reaction (qPCR) from RNA extracted from lymphocytes. Hypothesis: We expect higher GR gene expression and lower FKBP5 gene expression in chronic and delayed-onset PTSD trajectories compared to recovering and resistant trajectories. We will further examine the effect of GR and FKBP5 genotype, as well as WTC- related and lifetime trauma exposures, on GR and FKBP5 gene expression levels. Specific Aim 3: To examine differences in gene activity that may be programmed by environmental impact via epigenetic mechanisms, such as DNA methylation, which produces stable modifications in DNA, associated with the 4 PTSD symptom trajectories, focusing our work on the GR and FKBP5 genes in lymphocytes. Hypothesis: We expect lower GR methylation and higher FKBP5 methylation in chronic and delayed-onset PTSD trajectories compared to recovering and resistant trajectories. We will further examine the effect of GR and FKBP5 genotype, as well as WTC-related and lifetime trauma exposures, on GR and FKBP5 gene methylation levels. Additionally, we will bank samples for future gene expression and methylation studies of other candidate genes identified in Aim 2a. Specific Aim 4: To evaluate an integrative, theoretical model that evaluates genetic, epigenetic, psychosocial, environmental, and HPA axis determinants of PTSD in WTC responders. Using results from Aims 1, 2, and 3, we will use structural equation modeling to evaluate theoretical models of how candidate genes and epigenetic markers are associated with a current diagnosis and severity of PTSD; the role of HPA axis parameters in mediating these associations, and the degree to which psychosocial factors such as personality, psychiatric history, and coping; environmental factors such as WTC-related exposures and lifetime traumatic events; and training/preparedness may supplement and interact with effects of genetics, epigenetics, and HPA axis variables on risk for PTSD in WTC responders.